Core A Administrative Core

The central theme of this renewal P01 is to learn how the gut microbiota of newborn children could be
altered to reduce the risk of allergic asthma in later childhood. This will require extensive interactions among
epidemiological, environmental, immunologic and physiologic investigations of many potential influential
variables on the microbiota of mother and child and the interactions of these microbiota to influence the
developing immune system. These influences on early-life immune development likely contribute to the
subsequent risk of allergic asthma during childhood. This renewal P01's Administrative Core (Core A) will
again have the ultimate responsibility for assuring productivity and synergy among the four Projects and the
four other Cores. Core A, under the direction of the P01 Co-Program Directors Drs. Johnson and Ownby, is the
administrative umbrella responsible for optimizing scientific and operational output across this Program Project.
As in the initial P01, the continuing focus of Core A will be to provide for P01 oversight and integration.
Core A will oversee 1) communication and collaboration among Projects, Cores, investigators, consultants,
research and administrative staff, the External Advisory Committee, and NIH; 2) the quality of methodology,
data and analyses; 3) research output, primarily through presentation and publication, to promote effective and
timely dissemination of findings; and 4) the optimization of scientific and operational synergy. The Core A staff
will organize routine and special meetings to present and discuss results and ideas emanating from Projects
and Cores, set scientific agendas for these meetings, and appoint and support a Publications Committee and
External Advisory Committee. This Core will be responsible for promoting operational synergism and
effectiveness through monitoring progress and coordination of operational and administrative facets of the P01.
The Core A Directors will regularly review research activities, monitor the productivity and efficiency of all
Projects and Cores, maintain documents, and coordinate IRB, CEAC and progress report submissions among
the participating institutions. Core A will oversee matters of personnel, purchasing and fiscal management
including working with NIH and grants personnel at the subcontracting institutions.
This P01 is innovative in that it brings to bear expertise across multiple disciplines and institutions to
address a major childhood health problem, but it requires careful and attentive administrative approaches to
capitalize on this advantage while minimizing the attendant disadvantages of communication barriers
introduced by disciplinary jargon, specialized expertise, different scientific perspectives, and geographic
distance. While not without challenges, the Core A leaders and staff have benefited from the initial P01
experience and will assure processes are in place to once again optimize this P01 team's synergy and
productivity.